Engineering the Next Generation of T Cells

OVERALL SUMMARY
This U54 “Immuno-engineering to Improve Immunotherapy (i3) Center” was developed in response to
RFA-CA-19-013. The purpose of this U54 is to employ immuno-engineering principles to design more
durable, accessible, and less toxic immunoprevention and immunotherapy strategies. A national priority
set by the Cancer Moonshot initiative is to support studies incorporating next-generation genetic
engineering, engineered biomaterials, nanotechnology, computational and mathematical modelling, or
systems biology approaches in the design, implementation and evaluation of next generation
immunotherapies focused on overcoming immunosuppressive barriers, targeting tumor cells for killing,
and generating long-lasting anti-cancer immunological memory. The focus of our U54 entitled
“Engineering the next generation of T cells” is on developing next-generation gene-editing or
modification of immune cells to improve persistence in vivo, control and manipulate the immune system
to reduce oﬀ-target toxicities and enhance anti-tumor eﬀectiveness of adoptive cell therapy. Our central
hypothesis is that next generation engineering can improve the safety and efficacy of CAR T cells
while decreasing the cost of goods. There are three scientific projects in our U54 Center. The shared
goal of these projects is to enable this powerful therapy to reach a broader spectrum of patients with
blood cancer and solid cancers. In Project 1, we are using CRISPR/Cas9 to edit the epigenome of T
cells and to make cells resistant to cytokine release syndrome (CRS), while employing engineering
technologies to automate CAR T cell culture. The goal of Project 2 is to generate universal CAR T cells
(UCART) using advanced genetic editing technologies and then to compare UCAR to autologous CAR
T in a unique model of canine cancer. In Project 3 we will use advanced protein engineering, cell
engineering and oncolytic vectors to test synthetic cytokine and cytokine receptor systems in mouse
and human T cells, with the long-term goal of eliminating or reducing the need for lymphodepleting
conditioning chemotherapy prior to adoptive cell transfer. Our approach is multidisciplinary and multi-
institutional. We have brought together a cadre of exceptional investigators from multiple disciplines
who have collaborated and published together for many years. State of the art genetic editing with
CRISPR/Cas9 and cell culture technologies at the University of Pennsylvania are synergistically
coupled with world-class protein engineering and structural biology at Stanford University. Each project
is led by recognized authorities in the field.
The Administrative Core for this U54 is designed to manage and coordinate all i3 Center Research
Project activities and serve as the liaison between the i3 Center and the IOTN Data Management and
Resource-sharing Center (U24) and other Cancer Moonshot consortia, including the Pediatric
Immunotherapy Discovery and Development Network (PI-DDN). In addition, the Administrative Core
will coordinate collaborative research activities between the i3 Center Research Project PD(s)/PI(s) and
IOTN (or other) investigators. The potential for paradigm-shifting impact this U54 is to transform the
lessons of first-generation CAR T for leukemia and lymphoma into meaningful efficacy against all
malignancies.

Public health relevance
Overall Narrative Our goal is to develop next-generation genetic engineering for T cell therapies with the long-term goal of preventing the deaths of more than 600,000 people every year in the United States. Our approach involves the development of next generation therapies with chimeric antigen receptor (CAR) T cells, involving innovative combinations of CAR T cells, protein engineering and genetic editing with CRISPR/Cas9 technology with improved culture systems to improve affordability and reduce off-target toxicities, while enhancing anti-tumor effectiveness. Our team has provided paradigm-shifting impact in B cell malignancies and the projects in this U54 have the potential to create the next generation of engineered T cell therapies for solid cancers beyond hematologic malignancies with improved affordability and access for all cancer patients.